Genetically-Targeted Photo-Pharmacology for Native Opioid Receptors

PROJECT SUMMARY
In the nervous system, G protein-coupled receptors (GPCRs) sense neuromodulators to initiate
intracellular signaling cascades that control a plethora of brain functions. Of particular importance are the opioid
receptors which contribute to pain sensation, reward processing and mood regulation. Consistent with these
roles, opioid receptors serve as major drug targets for a variety of disorders. Agonists of the mu-opioid receptor
(MOR) are common analgesics and also have potential as antidepressants. However, a challenge with opioid-
based treatment is the propensity for addiction, tolerance and dangerous side effects. Unfortunately, limitations
in the precision of pharmacological approaches have hampered our ability to dissect the molecular, cellular and
circuit level mechanisms of MOR-mediated disease treatment and develop improved therapeutic strategies.
We previously established methodologies for optical control of GPCRs using photopharmacology, which
we will adapt for the MOR in the R61 phase. In aim 1, we will develop a range of new photoswitchable compounds
for the MOR using a combination of structure-based prediction, chemical synthesis and functional analysis. In
aim 2, we will adapt these compounds to make photoswitchable orthogonal remotely-tethered ligands (PORTLs)
which covalently attach to target receptors with a labeling tag, such as SNAP, CLIP or Halo. To enable targeting
of native receptors, we will further extend our system to develop nanobody-photoswitch conjugates (NPCs) which
bind to native receptors and deliver a PORTL for reversible optical control. NPCs can either be genetically-
encoded to permit cell type-targeting or can be purified in vitro and directly applied to the sample in a gene-free
approach. Together, this will provide a new, widely-applicable toolset for MORs while also developing an
engineering framework for extension of this approach across different receptor types.
In the R33 phase, we will harness our toolset in vivo to probe the basis of MOR-mediated antidepressant
effects in mice (aim 3). We hypothesize that activation of MORs localized on interneurons of the medial prefrontal
cortex (mPFC) induce disinhibition that leads to normalization of dysfunctional prefrontal circuits. PORTLs and
NPCs will enable targeting to the cell types and brain regions of interest with sufficient spatiotemporal precision
to probe the relationship between receptor activation and behavioral modulation. We will use behavioral assays
of relevance to depression, as well as measures of reward and dependence with the expectation that targeted
photo-activation can produce antidepressant effects with minimal side effects. To gain further mechanistic
insight, we will perform slice electrophysiology and in vivo 2-photon calcium imaging to measure the effects of
MOR activation on mPFC activity. This work will validate our toolset in vivo and provide a key step toward
understanding the mechanism of MOR modulation for depression treatment.

Public health relevance
PROJECT NARRATIVE Despite their prominent roles in the pathophysiology and treatment of pain, addiction and mood disorders, the mechanisms by which opioid receptors (ORs) control neural circuits and behavior remain poorly understood in large part due to limitations of classical pharmacological techniques which lack spatiotemporal control, subtype-specificity, pathway-specificity and targeting to genetically-defined cell types. In this proposal, we will develop a family of photopharmacological strategies for genetically-targeted optical control of native ORs to probe the cellular and circuit mechanisms of mu-OR-mediated anti-depressant treatment.